MYC-regulated RNA Binding Protein Networks and Spliced Isoforms Driving Cancer

SUMMARY
Alternative RNA splicing is a key step in gene expression regulation and contributes to transcriptional diversity
by selecting which transcript isoforms are produced in a specific cell at a specific time point. Aberrantly spliced
isoforms can impact every one of the hallmarks of cancer, including increased cell proliferation, migration, or
resistance to apoptosis. Regulatory splicing factors (SFs) have recently emerged as a new class of oncoproteins
and tumor suppressors. In particular, the tumorigenic capacity of the oncogenic transcription factor MYC, which
is dysregulated in >50% of human tumors, has been shown to be dependent on the splicing machinery and on
at least 3 SFs directly regulated by MYC. However, we currently do not have a comprehensive understanding of
which component(s) of the splicing machinery are regulated by MYC, or of the functions of MYC-induced spliced
isoforms. The goal of this proposal is to systematically characterize the mechanisms by which MYC-regulated
SFs and spliced isoforms drive tumor growth and maintenance. To begin to address this gap in knowledge, in
our preliminary studies we used a mammary cell line harboring an inducible form of MYC to greatly expand the
number of known SFs regulated by MYC. We uncovered that MYC activation promotes alternative splicing of
>4,000 isoforms and expression of 125 SFs. These SFs are also upregulated in MYC-active breast tumors and
can be grouped, based on co-expression, into groups or modules. Six SF-modules highly correlate with MYC
activity in breast tumors and cell lines, and are enriched in triple negative breast cancer (TNBC). Which of these
SFs play a role in MYC-driven transformation, and whether co-expression of multiple MYC-induced SFs has a
stronger tumorigenic effect than individual SFs, is not known. Further, co-expression analysis in 33 TCGA tumors
of different tissue origin identified an SF-module shared across all MYC-active tumors, suggesting a pan-cancer
vulnerability. We hypothesize that MYC regulates a network of SFs which cooperate in tumor pathogenesis and
that disrupting this network could provide a novel strategy to slow growth of MYC-driven tumors. Here, we will
leverage our expertise in RNA splicing and cancer biology and apply a functional genomics approach to gain
novel insights into MYC's oncogenicity. Aim 1 will characterize the function of 6 MYC-induced SF modules and
their splicing targets in TNBC tumor growth in vitro and in vivo. Since it is unknown whether MYC regulates a
shared set of isoforms in distinct tissues, Aim 2 will identify pan-cancer splicing signatures predictive of MYC
activity and clinical outcomes, which may serve as clinical biomarkers, and will deliver putative neo-antigens
generated from MYC-induced isoforms. Finally, Aim 3 will implement genomic approaches to determine which
MYC-induced isoforms are essential for the growth of MYC-driven cancer cells and patient-derived organoids.
This project will reveal fundamental mechanisms by which oncogenic SFs and their target spliced isoforms drive
tumorigenesis downstream of MYC. These results could help inform development of therapeutic strategies for
tumors driven by MYC, which remains an undruggable target.

Public health relevance
PROJECT NARRATIVE The oncogene MYC is one of the most commonly altered genes in human cancer, yet there are no FDA-approved MYC-targeting therapies due to a lack of a binding site for standard chemical inhibitors; therefore, it is imperative to develop alternative methods to treat MYC-driven tumors. Recent evidence indicates that the tumor-promoting activity of MYC requires RNA splicing, a process that determines which version of a gene is expressed within cells. In this research, we will identify which proteins controlling RNA splicing and gene versions are impacted by MYC to promote cancer, and we will thereby discover targets for the development of novel therapeutic strategies targeting RNA splicing in tumors and new markers that could be used for clinical diagnosis.